Improving outcomes for women experiencing premature or early menopause after cancer: development and pilot testing of a novel intervention

ABSTRACT
Premature (i.e., occurring before age 40 years) and early menopause (i.e., occurring at age 40-44 years)
significantly impact women (biological sex) treated for childhood, adolescent, or early-onset adult cancers.
Among these women, premature or early menopause are common, resulting from certain chemotherapies (e.g.,
alkylating agents), radiation treatments (e.g., pelvic radiation), surgeries (e.g., oophorectomy), and endocrine
therapies (e.g., ovarian function suppression). Premature and early menopause elevate the risk for
cardiovascular disease, ischemic stroke, type 2 diabetes, osteoporosis, cognitive decline, neurological disorders,
and depressive symptoms, which together result in an increased risk of morbidity and early mortality. The
significant long-term health impacts of premature and early menopause are further exacerbated by the effects
of women’s cancer treatments (e.g., chemotherapy-related cardiotoxicities). Women with premature or early
menopause after cancer also commonly experience symptoms such as hot flushes, sleeping problems, and
sexual dysfunction that have negative impacts on their daily activities and quality of life. There is a critical need
for novel interventions to address the many challenges faced by women experiencing premature or early
menopause after cancer. We propose to develop and pilot test a novel nurse navigator-delivered intervention
that is guided by the Empowerment Model for Managing Menopause and integrates 1) personalized, risk-based
menopause education and decision support guided by the Ottawa Decision Support Framework, 2) skills derived
from patient activation theory to improve knowledge, increase self-efficacy, and increase engagement in self-
management, and 3) cognitive behavioral based skills to manage menopausal symptoms. Intervention
development and initial evaluation are consistent with Stage 1 of the NIH Stage Model for Behavioral Intervention
Development. Aim 1. Preliminary intervention content will be developed with input obtained in interviews with
women (N=24) experiencing premature or early menopause after cancer and medical providers (N=24) who care
for this population. The prototype intervention will be refined with input by the study advisory council. Next,
women (N=9) experiencing premature or early menopause after cancer will receive the intervention and provide
feedback to further refine content, format, and procedures. Aim 2. Intervention feasibility and acceptability will
be examined in a pilot randomized controlled trial (RCT). A new sample of women experiencing premature or
early menopause after cancer will be randomized to receive the intervention or educational materials to examine
the feasibility of study recruitment (N=60 in 10 months), participant retention (>80% intervention completion) and
acceptability. We will also examine patterns of change in intervention targets (i.e., risk-based knowledge,
decisional conflict, self-efficacy, patient activation and menopausal symptoms) and exit interview data from
intervention participants.

Public health relevance
PROJECT NARRATIVE Premature (i.e., occurring before age 40 years) and early menopause (i.e., occurring at age 40-44 years) significantly impact women treated for childhood, adolescent, or early-onset adult cancers. The long-term health consequences, symptoms, and psychosocial impacts associated with premature and early menopause disrupt women’s daily activities and interfere with achieving important life goals. This study will develop and pilot test a novel nurse navigator-delivered intervention to help women make risk-based and values-driven menopause management decisions, reduce their symptom burden, and engage in menopause self-management to reduce negative health impacts.